Ex-vivo bioengineered technology to unravel dysfunction due to non-alcoholic steatohepatitis (NASH)

SUPPLEMENT SPECIFIC ABSTRACT
This submission is in response to the Research Supplement to Promote Diversity in Health-Related Research
(PA-23-189) and is aimed at developing the scientific skills and career development of the candidate. The
supplement is requested for grant R01DK132873 “Ex-vivo bioengineered technology to unravel dysfunction due
to non-alcoholic steatohepatitis (NASH)”. The parent research project grant centers on the disease NASH that
is the progressive form of non-alcoholic fatty liver disease and leads to liver fibrosis by creating an inflammatory
milieu that predisposes to liver cancer in the later stages of the disease. The goal of this Research Supplement
is to provide high quality mentoring to the candidate along with an invigorating research plan that models liver
fibrosis in the laboratory and assess its influence on molecular signaling pathways within iPSC-hepatocytes from
patients with and without NASH. Together, this Research Supplement is closely related to the goals of the parent
project through the use of already available, de-identified, disease-specific cells and tunable matrix
environments. The Research Plan also provides an extension, with an additional line of experimentation to
enable the candidate to develop a distinct but related research focus that will become the subject of a future
individual training grant. The mentors have a longstanding track record of collaboration in liver research,
successful joint mentorship of a trainee and experience with developing the research career of young scientific
investigators. The candidate will receive structured mentorship and practical scientific skill development to carry
out this hypothesis-driven research that altogether aims to develop a scientific identity for the candidate and
maintain trajectory toward a career in academic research. This is enabled by the Research Supplement that
provides a pathway for both scientific and career development that is delineated in the Research Plan and
Training Plan. While pursuing these research-related end-points, the candidate will receive guidance from the
mentoring team on career development objectives that center on: 1) honing scientific communication, both
written and oral, 2) professional networking at scientific meetings to expand a cadre of scientific collaborators,
and 3) limited classroom education that complements the Research Plan to augment an armamentarium of
investigative tools and techniques. Together, this Research Supplement will provide a solid foundation that will
launch the candidate’s graduate research trajectory and fortify a strong position for a successful transition into
an individual training award as a senior graduate student.

Public health relevance
SUPPLEMENT SPECIFIC NARRATIVE Approximately 15 million people in the United States are at risk for developing cirrhosis, liver failure, hepatocellular carcinoma and death due to non-alcoholic steatohepatitis (NASH), while there are less than 10,000 liver transplants performed annually in the United States. This Research Supplement adds to the training of the diverse biomedical workforce and, in doing so, will develop novel cell and bioengineering-based platforms to investigate the effect of matrix stiffness in NASH. Together, the improved understanding of these underlying mechanisms will aid in the development of new treatments for NASH and progressive liver fibrosis and dysfunction.